Flexible statistical machine learning techniques for cancer-related data

DESCRIPTION (provided by applicant): Gene expression provides a snapshot of the cellular changes that promote tumor malignancy. Quantitative gene expression analysis, especially as implemented by DNA microarrays, has identified many new important cancer related genes and led to the development of new genomic-based clinical tests. For the quantitative aspect of gene expression analysis, many statistical methods have been used to study human tumors and to classify them into groups that can be used to predict clinical behavior. Despite progress, with the rapid advance of technology, massive and complex data are being generated in cancer research. Analyzing such data becomes more and more challenging. These challenges call for novel statistical learning methods, especially for high dimensional and noisy data. The goal of this project is to develop a host of new statistical learning techniques for solving complicated learning problems. In particular, this project develops (1) novel techniques to assess statistical significance of clustering for high dimensional data;(2) several novel predictive models including classification and regression which are expected to yield highly competitive accuracy and interpretability;(3) new methods for high dimensional biomarker/variable selection;(4) new approaches to estimate high dimensional covariance/precision matrix for biological network construction. These new developments are expected to allow scientists to analyze complex cancer genomic data with accurate prediction accuracy and increased interpretability. The research team will apply the proposed techniques to cancer research data analysis. The success of this project will be important in bridging statistical machine learning and cancer research. PUBLIC HEALTH RELEVANCE: This project aims to develop a host of new statistical learning techniques for solving complicated learning problems, especially for problems with high dimensional and noisy data such as gene expression data. These new techniques are expected to allow scientists to analyze complex cancer genomic data with accurate prediction accuracy and increased interpretability.

Public health relevance
Project Narrative This project aims to develop a host of new statistical learning techniques for solving complicated learning problems, especially for problems with high dimensional and noisy data such as gene expression data. These new techniques are expected to allow scientists to analyze complex cancer genomic data with accurate prediction accuracy and increased interpretability.